Targeting physiologic changes as a route towards therapy for degenerative ataxias

DESCRIPTION (provided by applicant): In most inherited degenerative ataxias, selective loss of certain types of neurons occurs primarily in the cerebellum and brain stem despite widespread expression of the disease protein. Many of these selectively vulnerable neurons exhibit autonomous pacemaker firing. Neuronal dysfunction must precede the eventual loss of neurons in ataxia, but the nature of this neuronal dysfunction and its causal relationship to motor symptoms are not well established. My preliminary studies in a mouse model of the polyglutamine disorder Spinocerebellar Ataxia Type 3 (SCA3) have identified altered firing properties of one class of pacemaker neurons, the cerebellar Purkinje neurons, and have shown that transiently correcting this aberrant physiology with a potassium channel activator improves the motor phenotype in SCA3 mice. The studies proposed here, which take advantage of my expertise in electrophysiology and will be performed in a leading SCA3 laboratory, will test the hypothesis that the selective neuronal vulnerability observed in SCA3, and possibly other polyglutamine ataxias, reflects alterations in the properties of neuronally expressed potassium channels. The proposal has 3 aims. Aim 1 will examine the firing properties of various affected pacemaker neurons in SCA3 and determine whether alterations in potassium channel physiology can explain the observed changes in firing properties. Aim 2 will determine the mechanism for polyglutamine disease protein-induced changes in potassium channel biophysics. Aim 3 will examine whether modulators of potassium channel physiology can improve the motor symptoms in SCA3 mice. The overall objective of these studies is to determine whether such physiologic changes are promising targets for symptomatic or preventive treatment of these currently untreatable disorders. The impact of these studies will be to move the field of degenerative ataxias, which has focused primarily on changes in brain morphology and biochemistry, towards looking at specific, early and potentially modifiable changes in neuronal function. My career goal over the next five years is to become an independent researcher with the expertise to investigate the physiologic underpinnings of SCA3 and related ataxias and to design and test pharmacologic agents that can serve as a route to therapy for these currently untreatable disorders. My long term goal is to secure and succeed in a tenure-track faculty position at a neurology department at a major institution, combining the care of patients with movement disorders and heading a research laboratory that continues to interrogate the role of ion-channels in the pathogenesis of degenerative ataxic disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Spinocerebellar ataxia type 3 (SCA3), the most common dominantly inherited form of ataxia, causes loss of balance and coordination in patients and is associated with a loss of nerve cells in certain brain regions, notably the cerebellum and brain stem. This proposal examines whether correcting perturbations in the electrical properties of nerve cells in these affected brain regions in SCA3 will lead to the development of new drugs to treat this currently untreatable, fatal disorder. Project Narrative Spinocerebellar ataxia type 3 (SCA3), the most common dominantly inherited form of ataxia, causes loss of balance and coordination in patients and is associated with a loss of nerve cells in certain brain regions, notably the cerebellum and brain stem. This proposal examines whether correcting perturbations in the electrical properties of nerve cells in these affected brain regions in SCA3 will lead to the development of new drugs to treat this currently untreatable, fatal disorder. __SpecificAimsTextDelimiter__ Specific Aims In most inherited degenerative ataxias, selective loss of neurons occurs primarily in the cerebellum and brain stem despite widespread expression of the disease protein. Many of the selectively vulnerable neurons in various ataxias, including Purkinje neurons, neurons of the deep cerebellar nuclei (DCN), and substantia nigra neurons, exhibit autonomous pacemaker firing. Although neuronal dysfunction must precede the eventual loss of neurons in these disorders, both the nature of this neuronal dysfunction and its causal relationship to motor symptoms are not well established. My preliminary studies in a mouse model of the most common spinocerebellar ataxia (SCA), the polyglutamine disorder SCA3, have identified aberrant depolarization and reduced firing of cerebellar Purkinje neurons at an early stage of motor dysfunction. Voltage-activated potassium (Kv) currents in Purkinje neurons of SCA3 mice show increased inactivation and an activator of calcium-activated potassium currents partially corrects this abnormal firing of SCA3 Purkinje neurons. In short term studies, this activator also improves the motor phenotype in SCA3 mice. The studies proposed here, which take advantage of my expertise in electrophysiology and will be performed in a leading SCA3 laboratory, will test the hypothesis that the selective neuronal vulnerability observed in SCA3, and possibly other polyglutamine ataxias, reflects alterations in the properties of neuronally expressed potassium channels. The impact of these studies will be to move the field of degenerative ataxias, which has focused primarily on changes in brain morphology and biochemistry, towards looking at specific, early and potentially modifiable changes in neuronal function. The overall objective is to determine whether such physiologic changes are promising targets for symptomatic or preventive treatment of these currently untreatable disorders. Aim 1: Define altered physiological properties in affected neuronal populations in SCA3. Hypothesis: Increased inactivation of delayed rectifier potassium channels results in increased excitability of DCN and brain substantia nigra neurons, two additional groups of pacemaker neurons that are selectively vulnerable in SCA3. My preliminary results have identified a change in intrinsic firing of SCA3 Purkinje neurons, but other pacemaker neurons in the DCN and substantia nigra also commonly degenerate in SCA3. Using patch-clamp recordings of DCN and substantia nigra neurons in SCA3 transgenic mice, I will determine whether altered firing properties of pacemaker neurons is a more generalizable phenomenon. If changes are observed, I will determine whether perturbed potassium channel physiology likewise explains the altered firing properties. Aim 2: Determine why potassium channel properties are altered in SCA3. Hypothesis: Mutant ataxin-3 directly interacts with pore-forming potassium channel subunits to alter their biophysical properties. Preliminary experiments suggest that mutant (i.e. expanded) ataxin-3 alters inactivation of the Kv channel, Kv3.1. In cell lines stably expressing different potassium channel subunits, I will use electrophysiology to determine whether mutant ataxin-3 can affect their biophysical properties. In parallel studies, immunoprecipitation will be used to determine whether ataxin-3 directly interacts with potassium channel subunits and, if so, whether this interaction is polyglutamine length-dependent or dependent on ataxin-3 function. Further studies will assess whether other expanded polyglutamine disease proteins implicated in dominantly inherited ataxias cause similar alterations in potassium channels. Aim 3: Test whether modulating potassium channels improves the motor phenotype in SCA3 mice. Hypothesis: Increasing the effective potassium current in SCA3 neurons will improve firing properties and improve the motor phenotype in SCA3 mice. Using pharmacologic activators of calcium-activated potassium channels or disinactivators of Kv channels, I will determine whether boosting the effective potassium current in SCA3 neurons improves neuronal physiology and motor behavior in SCA3 mice. I will also determine whether crossing SCA3 mice to mice lacking Kvbeta1.1, the potassium channel accessory subunit that normally promotes inactivation of Kv channels, improves the firing properties of neurons in cerebellar slices and the motor phenotype in SCA3 mice. Results from these studies are expected to establish that alterations in potassium channel physiology contribute to the pathogenesis of SCA3. Targeting potassium channel physiology is a promising therapeutic target for SCA3 and possibly other polyglutamine ataxias, all of which are relentlessly progressive and currently untreatable disorders.